Elucidating the link between Mycobacterium tuberculosis potassium homeostasis and its lipid metabolism and growth in vivo

PROJECT SUMMARY/ABSTRACT
Successful host colonization by Mycobacterium tuberculosis (Mtb) requires that the bacteria sense and
respond to disparate environmental cues coordinately during infection, and adapt its physiology accordingly.
This includes an ability to respond to acidic pH and maintain intrabacterial ionic homeostasis, as well as
utilization of lipid carbon sources during infection. However, how Mtb ionic cue response and homeostasis and
its lipid metabolism are functionally connected remains poorly understood. Intriguingly, we have found that Mtb
lipid metabolism and its potassium (K+) response/homeostasis is linked. For example, the bacterial response to
cholesterol is repressed upon disruption of intrabacterial K+ homeostasis, and growth in cholesterol media of a
Mtb mutant disrupted in K+ homeostasis is impeded at pH 7, but not pH 6. Aim 1 of this proposal thus seeks to
define the global impact of Mtb K+ homeostasis disruption on the bacterium’s ability to utilize cholesterol,
examining both transcriptional response and utilizing a fluorescent cholesterol tracer for the analysis of
cholesterol uptake. Aim 2 focuses on understanding the functional impact of local environmental differences on
intrabacterial K+ homeostasis and Mtb replication status during infection, with single bacterium resolution. It will
exploit the use of a novel fluorescent reporter that reports on intrabacterial K+ levels, with tests on wild type
Mtb and mutants in several key lipid utilization regulators. Single bacterium level analysis in vivo is particularly
critical due to the marked heterogeneity in both local pH and nutrient sources experienced by Mtb during
infection, which extends to non-uniformity spatially within canonical caseous necrotic lesions. As such, Aim 2
studies will further exploit combination of a fluorescent replication reporter with a Mtb mutant disrupted for
intrabacterial K+ homeostasis, in a murine infection model that recapitulates highly structured caseous necrotic
lesions observed during human infection. These in vivo experiments will enable elucidation of how differences
in local environment (pH, carbon source etc.) during infection may alter the relative need for active
maintenance of intrabacterial K+ homeostasis by Mtb for replication success. This project is conceptually
innovative in examining how Mtb K+ homeostasis affects its lipid metabolism in a pH-dependent manner, an
intersection of vital aspects of Mtb infection biology that is unexplored. There is further methodological
innovation in the development of a new intrabacterial [K+] reporter to delineate the impact of local environment
in vivo on Mtb K+ homeostasis. These studies will provide the foundation for understanding the concept of an
intrinsic link between Mtb metabolism and ionic cue response and homeostasis, a facet of Mtb infection biology
that holds the potential for exploitation for therapeutic purposes.

Public health relevance
PROJECT NARRATIVE Successful host colonization by Mycobacterium tuberculosis (Mtb) requires that the bacterium coordinate its response to the local environment with its physiology, to ensure appropriate adaptation and continued survival, but the functional link between these two critical facets of Mtb biology remains poorly understood. This proposal seeks to elucidate the relationship between intrabacterial potassium homeostasis and Mtb cholesterol utilization, and the role of environmental pH in modulation of this interplay. Such understanding of the intrinsic link between Mtb metabolism and ionic cue response and homeostasis will reveal new Achilles’ heels of the bacterium that can be targeted to shift the balance of infection in favor of the host.